Predictors of Youth-Onset Type 2 Diabetes: UAB Clinical Center

Minority youth are at elevated risk for type 2 diabetes (T2D) relative to non-Hispanic whites (NHW), with
African-Americans (AA) and Hispanic-Americans (HA) showing the greatest increase in prevalence since 2000.
Our overarching hypothesis is that underlying genetic differences in minority children interact with
environmental factors in an adverse manner to increase risk for T2D. For example, the elevated beta-cell
responsiveness and reduced hepatic insulin extraction exhibited by AA may increase risk for obesity and beta-
cell dysfunction in the context of a diet high in sugar and processed starches. HA have both a genetic
predisposition to fatty liver, due to a mutation in the carbohydrate-responsive PNPLA3 gene, and a genetic
impairment in the ability to expand peripheral adipose tissue. In the context of weight gain and a high-
sugar/processed carbohydrate diet, these genetic factors may increase risk for insulin resistance. The global
purpose of RFA-DK-21-002 is to identify factors that predict conversion to T2D, and that disproportionately
predispose minority youth to T2D. With our “University of Alabama at Birmingham (UAB) Clinical Center,” we
propose to recruit, phenotype, and follow for 5 years 100 at-risk youth aged 8-16 yr without T2D at baseline
comprised primarily of AA children with extreme obesity. Our team excels in assessment of insulin sensitivity
and beta-cell function; assessment of body composition and body fat distribution; evaluation of the intrauterine
environment; and conducting longitudinal cohort studies with high retention. Published data indicate that the
greatest risk factors for pediatric T2D are extreme obesity (BMI z score > 2.5), impaired glucose tolerance (2-h
glucose >140 mg/dL and <200 mg/dL), weight gain, and family or maternal/gestational history of diabetes. We
will assess all of these variables with annual testing visits that will include an oral glucose tolerance test and
dual-energy-X-ray absorptiometry (DXA) for body composition and fat distribution. In addition, we will collect
genetic material for assessment of targeted SNPs with known association to T2D risk, and we will assess
environmental factors such as psychosocial variables and diet. Sera/plasma will be archived for future
metabolomics. Prediction models will be developed for incident T2D, as well as for prevalent and incident IGT,
using suites of anthropometric/demographic, phenotypic, and genotypic variables. We hypothesize that
ethnicity/race will not be statistically related to incident T2D when accounting for genotypic and/or phenotypic
factors that affect risk for T2D, and their potential interaction with environmental factors. Results from this
study will identify the genetic underpinnings of the phenotypic and anthropometric/familial factors that
associate with, and reflect the pathophysiology of, IGT and T2D, and will determine whether these
determinants differ with ethnicity/race. As such, the results of this study will identify targets for intervention,
and markers for monitoring intervention effectiveness, that can be utilized in subsequent intervention studies.

Public health relevance
PROJECT NARRATIVE Minority youth are at elevated risk for type 2 diabetes (T2D) relative to non-Hispanic whites (NHW), with African-Americans (AA) and Hispanic-Americans (HA) showing the greatest increase in prevalence since 2000. Our overarching hypothesis is that underlying differences in genes and physiology in minority children interact with environmental factors in an adverse manner to increase risk for T2D. This study will follow 100 at-risk youth aged 8-16 yr for 5 years to identify factors that predict conversion to T2D, and determine why conversion to T2D is more likely among minority youth.